The Rhode Island Young Adult Prescription and Illicit Drug Study (RAPIDS): Responding to Fentanyl and Associated Harms

PROJECT SUMMARY No change from what was originally proposed

Public health relevance
PROJECT NARRATIVE No change from what was originally proposed